Investigating disseminated cancer cell clonal cooperation and immune control in dormancy and metastasis

SUMMARY. We revealed that cancer cells can disseminate from early stages of cancer progression and after
variable periods of dormancy they go on to form metastasis. Knowledge about how early DCCs (eDCCs) shape
metastatic progression, how they remain dormant and immune evasive for years and how they get reactivated,
is limited, but critically needed to develop more effective treatments. We discovered that as the primary tumor
evolves genetically and grows, target organs are seeded by more genetically evolved late DCCs (L-DCCs) that
can be dormant but also may carry more growth prone programs. How the first arriving eDCC and following L-
DCCs crosstalk to affect immune niches in the lung for metastasis development has never been explored. Using
genetic lineage tracing, protein barcoding, and single cell RNAseq (scRNAseq) we found that 79% of metastasis
were derived from eDCCs and that eDCCs and L-DCCs cooperate in lungs to initiate metastasis. We also
discovered that dormancy of eDCCs is driven by ZFP281 and NR2F1 and that interaction of eDCC and L-DCC
downregulates NR2F1 expression to cooperatively found metastasis. Mouse models and human data suggest
that immune-surveillance does not fully eliminate eDCCs, but how eDCCs evade immune targeting is unclear.
To this end, we discovered that eDCCs have a low mutational burden, downregulate MHC-I compared to L-
DCCs and upregulate the immune suppressors Gal-1 and TGFβ2. In Lungs with eDCCs CD4 and CD8 T cells
seem to be dysfunctional, as depletion of CD8 T cells does not lead to eDCC outgrowth and treatment with anti-
PD-L1 therapy does cause eDCC eradication. We also find that tissue resident alveolar macrophages (AMs)
maintain dormancy of eDCCs but may contribute to immune evasion while also suppressing metastatic
outgrowth. We hypothesize that eDCCs and L-DCCs cooperate to found metastasis by (a) the ability of L-DCCs
to awaken dormant eDCCs via the production of inhibitors of pro-dormancy pathways and (b) eDCCs creating
immune-suppressive lung niches that allow more immunogenic L-DCCs to escape detection. We will test 1) the
role of clonal cooperation and metastasis founding capacity between eDCC and L-DCCs, 2) the molecular
mechanisms used by DCCs to protect themselves from immune clearance and 3) how L-DCC and lung alveolar
macrophage (AM) crosstalk affects eDCC reawakening and metastatic growth. Exploring these questions will
provide insight into novel immune evasive mechanisms by early and late cooperating DCCs that may be targeted
during dormancy or reactivation with immune targeting approaches to eradicate them. We also may discover
ways to prevent cooperating early and late DCCs from founding metastasis using activators of pro-dormancy
programs. Our work might explain why despite cancer cells disseminating early, removal of early stage tumors
(e.g. DCIS)reduces metastatic relapse, and why PT size is a poor prognosis indicator: namely that early DCCs
remain dormant unless reactivated by late DCCs that are more frequent the later a tumor is removed.

Public health relevance
NARRATIVE. In this proposal we will determine 1) how clonal cooperation between early (e) and late (L) evolved disseminated cancer cells (DCCs) influences metastasis initiation 2) how eDCCs are immune evasive and 3) how L-DCC and tissue-resident macrophage crosstalk affects DCC reawakening and metastatic growth.